Medical Image Perception Society XIX Conference

MIPS XIX brings together an international community of experts from different fields including radiologists, pathologists, other image-based clinicians, psychologists, statisticians, physicists, engineers, and computer scientists, all investigating the extraction of diagnostic information from medical images. The meeting forges research and learning opportunities for new trainees and young researchers in a dedicated multidisciplinary forum unmatched by other meetings. MIPS XIX is being organized by the Medical Image Perception Society (a US-based society; Elizabeth Krupinski, PhD President) in conjunction with local hosts Karla Evans, PhD (University of York Psychology) and Mark McEntee, PhD (University College Cork Clinical Therapies); and committee (University of York) trainee member Emma Raat. It will run July 19-21, 2021 at the Novatel York Centre located near the University of York campus. Nine topic areas have been selected for MIPS XIX, reflecting important dimensions of medical image interpretation. This year’s special focus themes are 1) Improving Diagnostic & Screening Performance (or outcomes) in Radiology Using Human & Machine Expertise and 2) Technological & Human Interventions for Enhancing Medical Image Perception. Studying how clinicians extract diagnostic information from images identifies the causes of missed diagnoses and ways to eliminate these errors. Careful design and evaluation of imaging systems are critical in view of their enormous costs. With the current emphasis in the practice of medicine on “meaningful use” and “accountable care” to improve the quality, safety, and efficiency of care, the role the clinician as decision-maker cannot be ignored. Medical image perception research develops and applies modern methods to the evaluation of observer performance in diagnostic imaging tasks. Understanding basic aspects of the perception of medical images can reduce diagnostic error and improve medical decision-making quality. This grant will support 10 students to attend and present their research at MIPS XIX. To date, 122 students have been awarded scholarships. The primary goal in supporting these students is to create opportunities and offer supportive mentoring at this formative stage in the trainee’s career to enhance their research potential and likelihood of success.

Public health relevance
The meeting brings together diverse researchers investigating the process of extracting diagnostic information from medical images to render accurate and efficient diagnostic decisions. Opportunities for advanced, interdisciplinary training of young scientists interested in medical image perception research and its relevance to disease prevention and treatment are often quite limited at the university level. Since 1997, 122 trainees have been awarded MIPS scholarships, having a significant impact on the field by creating opportunities and offering supportive mentoring at this formative stage in the trainee’s career to enhance their research potential and likelihood of success as independent basic science and clinician-scientist researchers.